Human Studies Core

PROJECT SUMMARY
Brain injury and stroke are leading causes of death and disability in New Mexico. Given the significant public
health impact of these conditions, it is vital to enhance understanding of brain recovery and repair and develop
innovative interventions to improve outcomes and quality of life for affected individuals and their families. In
Phases 1 and 2, the Center for Brain Recovery and Repair’s Clinical Core emerged as a regional leader in brain
injury research, addressing the urgent need for innovations in prevention, early intervention, and long-term
support for survivors of traumatic brain injury (TBI), stroke, and related disorders. These initial phases solidified
the Clinical Core’s position and reputation, attracting increased investment and partnerships while enhancing
faculty recruitment and retention at UNM. Accelerating research and evaluating new clinical treatments require
interdisciplinary collaborations, integrating the unique skills and knowledge of both preclinical and clinical
researchers to advance interventions from bench to bedside. Investigators from many different disciplines can
now collaborate and access state-of-the-art equipment and expertise that is unavailable elsewhere at the
institution or in the state. In Phase 3, the Clinical Core will continue to work towards the long-term goal of
developing a cutting-edge clinical intervention research facility that provides leadership, mentoring, and training
for emerging investigators focused on brain recovery and repair. The Core will continue to serve as a hub for
vibrant interdisciplinary collaborations and support a critical mass of researchers. The specific aims for Phase 3
include: 1) strengthening and expanding the Core’s user base, 2) continuing to support and expand Core
infrastructure, and 3) refining strategies to sustain Core operations beyond Phase 3. A robust pilot project
program will be utilized to attract new users to the Clinical Core and drive innovations in the field. Building on a
tradition of strong collaboration with Preclinical Core researchers, interdisciplinary seminars, workshops, and
events will be continued to foster interaction. Existing partnerships will be strengthened, and new relationships
with other departments and centers will be established. In Phase 3, the Core will enhance its traditional services
by integrating specialized and portable technologies that provide more accessible capabilities and research
possibilities. Key equipment resources will continue to be expanded in three thematic areas of clinical
neuroscience research: brain stimulation and modeling, neurobehavioral assessment, and neurophysiological
recording and neuroimaging. Continuous evaluation of progress will occur in coordination with the Administrative
Core, allowing for iterative improvements in the functioning of the Clinical Core and support for users. These
initiatives will further solidify the Center's reputation for building and sustaining research careers, making
significant contributions to brain injury research, and ensuring long-term sustainability beyond Phase 3.